Flow-informed therapy for glioblastoma

Project Summary
Glioblastoma is a deadly brain cancer marked by extensive invasion into the surrounding brain. Interstitial fluid
flow is heightened during disease development and is a major driver of tumor progression. These fluid flows in
and around brain tumors are heterogeneous and can be mapped by using our mathematical modeling approach
that uses a single patient or mouse’s dynamic MRI to generate 3D maps of interstitial transport quickly and
robustly. Interstitial flow not only changes during tumor progression, but can also change in response to anti-
tumor therapy, but the ways in which this happens and the dynamism of these changes are relatively unknown.
Here we propose to focus on interstitial fluid flow in glioblastoma to target treatments, assess treatment efficacy,
and plan treatment using a range of in vivo and mathematical modeling tools alongside advanced engineering
and imaging methodology. First, we will leverage the finding that interstitial fluid flow and transport can be used
to identify invading tumor cells to target treatment via focused ultrasound mediated blood brain barrier opening,
developing a novel precise FUS system coupled with both validation and treatment to target invasive tumor cells
preclinically on demand. Next, we will develop methodology to compare flow fields over the course of a series of
standard of care treatments (temozolomide and radiation therapy), physical drug delivery methods (convection
enhanced delivery and focused ultrasound), and antibody based targeted therapies (anti-VEGF and anti-PD1).
In this way, we will assess the changes to flow acutely and longitudinally and correlate these outcomes with
tumor growth and progression. Last, we will leverage advanced computational methods to use initial interstitial
flow fields and transport metrics to map drug delivery and disease progression. Founded on our basis of
preliminary data we will create physics-based mathematical models to determine the best flow directed
therapeutic strategies and will validate our approach with in vivo studies. Overall, this work leverages an
untapped biophysical biomarker, interstitial fluid flow, in glioblastoma to target treatment, understand treatment
responses, and plan treatment. With this new understanding of the dynamics and significance of interstitial fluid
flow in treatment of GBM, we can translate our methodologies and outcomes to patients.

Public health relevance
Project Narrative Interstitial fluid flow is the flow within the spaces of tissues and is a known driver of tumor progression and a critical factor in drug delivery. Glioblastoma is an invasive brain cancer marked by heterogeneous interstitial flow which can be mapped by MRI and advanced computational analysis. Here we leverage interstitial flow to target, monitor, and ultimately improve therapeutic outcomes in glioblastoma.